Head impact biomechanics, neurobehavioral health, and community perspectives on safety in youth ice hockey

Project Summary / Abstract
Ice hockey’s growing popularity includes over one million athletes in the US and Canada with a strong increase
in participation among females and adolescents. The sport has relatively high concussion rates compared to
others, including football, as it is a fast-paced sport with ice and board surfaces. Subconcussive head impact
exposure (HIE) has been associated with short- and long-term neurobehavioral changes. Detailed information
about head impact biomechanics and neurobehavioral health in this young and developing population are
lacking. Our study leverages multidisciplinary expertise to relate biomechanics-based metrics to athlete and play
characteristics and neurobehavioral health. We will implement advanced measurement and analytical
approaches characterizing HIE in adolescent boys’ and girls’ ice hockey players. This goal addresses an unmet
need to intersect these study elements to inform safety recommendations to improve the sport’s safety. Dr. Joel
Stitzel (WFU, MPI) has developed and employed an innovative instrumentation system, and video and data
processing strategies and algorithms to adequately contextualize HIE. Dr. Jason Mihalik (UNC, MPI) has strong
experience studying youth hockey head impact biomechanics and neurobehavioral outcomes. Combined, our
inter-institutional multidisciplinary team has a proven record deploying head impact technologies in the field,
working with adolescent athletes, studying neurobehavioral outcomes, and translating key findings into
recommendations and policy changes to improve athlete and sport safety. Together, we will address our central
hypothesis that biomechanics informs understanding of HIE in the context of athlete and play characteristics,
and HIE among adolescent ice hockey players elucidates neurobehavioral health effects (i.e., executive function,
impulsivity). This will serve as a paradigm to evaluate key community members’ awareness and receptivity to
strategies to improve safety by reducing HIE. This addresses our long-term goal to use head impact
biomechanics to improve sport safety more broadly. Our specific aims are to (1) Characterize head impact
biomechanics and neurobehavioral health in adolescent boys’ and girls’ ice hockey, (2) Evaluate the relationship
between athlete and play characteristics and HIE while controlling for neurobehavioral health, and (3) Determine
the awareness and receptivity among key community members to using biomechanical data to improve head
impact safety in ice hockey. We will accomplish this by using innovative mouthpiece-based instrumentation and
neurobehavioral measures (Aim 1), using time synchronized video to identify head impact biomechanics event
context and controlling for neurobehavioral health outcomes (Aim 2), and using a community-engaged approach
to assess knowledge, attitudes, and perceptions of hockey HIE and concussions (Aim 3). We will develop a
comprehensive understanding of HIE in boys’ and girls’ youth hockey grounded in accurate HIE metrics and their
relationship to athlete and play characteristics and neurobehavioral health. This will facilitate discussions of
receptivity to strategies to reduce HIE and concussion risk and increase benefits of participation in ice hockey.

Public health relevance
Project Narrative This study characterizes head impact biomechanics and neurobehavioral health in adolescent boys’ and girls’ ice hockey and evaluates the relationship between athlete and play characteristics and head impact exposure and concussion while controlling for neurobehavioral health. Innovative instrumentation and video review approaches are used to contextually analyze head impact exposure and relate it to neurobehavioral health. A community engaged approach is employed to determine awareness and receptivity among key stakeholders to using biomechanical data to inform strategies to improve head impact safety in hockey.